Exploiting iPLA2β-modified macrophages as immunotherapy for T1D

PROJECT SUMMARY
Type 1 diabetes (T1D) is an autoimmune disease characterized by the destruction of pancreatic b-cells,
however, the mechanisms leading to b-cells destruction are not completely understood. We identified a critical
role for proinflammatory lipids produced by macrophages (MΦ) in T1D onset. Such lipids were generated by
activation of the Ca2+-independent phospholipase A2β (iPLA2b). As a member of the PLA2 family, iPLA2b
hydrolyzes membrane phospholipids at the sn-2 position to release a fatty acid, such as arachidonic acid (AA),
which can be metabolized to bioactive oxidized lipids (eicosanoids). Several of these lipids are profoundly
proinflammatory and we find that they are dramatically elevated during the pre-diabetic phase, suggesting their
critical contribution to T1D onset. The MΦ are among the first to infiltrate islets and they can be induced to a
proinflammatory (M1) or anti-inflammatory (M2) phenotype. In T1D, MΦM1 predominate. We find that inhibition
or genetic global reduction of iPLA2b decreases proinflammatory iPLA2b-derived lipids (piDLs) production by MΦ
in the pre-diabetic phase, disfavors MΦM1, and reduces insulitis and T1D incidence in the non-obese
spontaneous diabetes-prone (NOD) mice. Importantly, non-diabetic children at high risk for developing T1D,
exhibit a similar plasma lipid signature. These findings raise the possibility that by reducing MΦ-iPLA2b, piDLs
production and induction of MΦM1 can be mitigated and that this will be beneficial in preventing or delaying T1D
onset. Among the piDLs are DHETEs, generated downstream of iPLA2b via CYP450/soluble epoxide hydrolase
(sEH). Inflammation relief has been reported with sEH inhibition, offering a select iDL-generating target to
counter T1D. We hypothesize that reducing MΦ-piDLs will disfavor MΦM1 and counter T1D development.
Recent advances in the CRISPR-Cas9 field have facilitated cell-specific and select genetic modification of
genes. Our findings present a novel, and not yet considered scenario, where reducing iPLA2b in MΦ using
CRISPR-Cas9 can be developed into an immunotherapy to counter T1D in humans. We propose to address this
under Aim 1. Assess the impact of MΦ-iDLs on T1D development. We will determine the impact of MΦ-iDLs
on T1D onset and progression using NOD mice with conditional modification of iPLA2b in MΦ. Aim 2. Establish
genetically-modified MF as potential immunotherapy to counter T1D development. Develop CRISPR-
Cas9 protocols to generate and assess functionality of MΦ derived from NOD bone marrow monocytes with
reduced iPLA2b or sEH1 expression and determine their impact on T1D incidence. Significance. Our proposal
addresses two novel concepts: (1) piDLs produced by MΦ are important contributors to b-cell death in T1D and
(2) manipulating lipid-generating enzymes in MΦ (a readily accessible pool) can counter T1D. We feel that
exploiting these will allow generation of novel immunotherapeutic avenues to prevent or delay T1D diagnosis in
the clinical setting. This premise is in line with the high risk/high reward mission of the R21 mechanism, readily
testable by our group, and expected to yield significant advances in the field of T1D therapy.

Public health relevance
Narrative Type 1 diabetes (T1D) is a consequence of autoimmune destruction of b-cells and immune cells play a critical role in the onset and progression of events that lead to b-cell death. Our lab has reported that lipid signaling generated by macrophages participates in this process. Our studies are aimed at modifying the macrophages to reduce such lipid production and develop a macrophage-based immunotherapy to curb the onset/development of T1D.